PEDIATRIC LATE OUTCOMES--INFANTS AND CHILDREN WITH HIV INFECTION

The object of this protocol is to define late outcomes of HIV infection and its drug therapy, including effects on growth, neurologic function, development, occurrence of malignancy, and immunologic and virologic parameters.